The Impact of Product Packaging on Appeal, Knowledge and Risk Perceptions of Cannabis Edibles

Project Summary
The rate of cannabis legalization in the U.S. has increased rapidly in recent years. This has led to the
proliferation of non-combustible cannabis products, like edibles (cannabis-infused food products), that do not
involve inhaling toxic smoke, can be used with discretion, and have no smell. While popular in recreational
states, these products pose unique public health challenges. Although edibles are packaged as appealing food
products and are perceived to be less harmful than other cannabis products, there is an increased risk for the
overconsumption of tetrahydrocannabinol (THC), the psychoactive component in cannabis. While smoking
cannabis results in an immediate high, intoxication from consuming edibles can be delayed up to two hours or
more and last up to 12 hours. This can lead to consuming more than the recommended serving, which can
result in unexpected, stronger, and longer-lasting highs as well as severe intoxication, cardiovascular effects,
and psychotic episodes. Since cannabis is regulated on a state-by-state basis, there is substantial variation in
the regulation of product packaging and warnings that inform consumers. Furthermore, little research has been
conducted on edibles, resulting in significant gaps in understanding how packaging and warnings impact
product appeal, knowledge, harm perceptions and willingness to try edibles. This R01 will address these gaps
by testing the impact of cannabis edibles product packaging and warnings using controlled, experimental
designs. First, we will content analyze text and visual packaging elements of a sample of products marketed
online. We will conduct two experiments to evaluate the impact of these elements on product appeal and harm
perceptions (Aim 1). Next, we will convene an expert panel that will evaluate existing edibles warnings and
develop an expanded warning to convey additional information about dosing and acute consequences. This
warning will be paired with an icon to increase attention. Warnings will be tested in an experiment to evaluate
their impact on communicating knowledge (Aim 2). Finally, in a combined experiment, we will test the impact
of the edible warning developed in Aim 2 in the context of package marketing (identified in Aim 1) on appeal,
knowledge, harm perceptions and willingness to try edibles in a nationally representative sample (Aim 3).
Given the rapid pace of legalization, coupled with the responsibility of informing consumers about safe
consumption and the risks of use, the scientific evidence generated from this study will be timely and is
urgently needed by state policymakers as they develop informed regulations, including best practices for
communicating knowledge to minimize harms. This application is directly responsive to NIDA’s research
priority areas outlined in NOT-DA-19-065 (Public Health Research on Cannabis), including the impact of
cannabis industry practices like marketing and warnings on cannabis use and outcomes.

Public health relevance
Project Narrative Cannabis edibles pose unique public health challenges as they are packaged as appealing food products and may be perceived as less harmful than smoking cannabis, despite the greater danger of severe intoxication. Because their psychoactive effects are delayed and longer lasting, it is difficult for users to titrate their dose which can result in the overconsumption of high amounts of tetrahydrocannabinol (THC) and acute adverse consequences. This project will address gaps in our understanding of how edibles package marketing contributes to harm perceptions and risk for overconsumption and how to effectively communicate knowledge about safe consumption through package warnings to guide state policymakers as they establish state regulatory guidelines for cannabis edibles to minimize harms and protect public health.